LYMPHOCYTE PHENOTYPES IN NORMAL INDIVIDUALS USING DUAL COLOR FLOW CYTOMETRY

Normal perIpheral blood lymphocytes are being evaluated using dual color flow cytometry to assess lymphocyte phenotypes. Comparison of two methods for cell preparation also form part of the current study.